Transcriptomic and Epigenomic Investigation of Antidepressant and Non-Hallucinogenic Serotonin Receptor Agonists

PROJECT SUMMARY
Roughly 15% and 8% of adults in the United States experience a substance use disorder or major
depressive disorder, respectively. The psychedelic class of medicines with agonism at the serotonin 2A
receptor has shown promise for treatment of each of these; however, the often concomitant hallucinatory
effects diminish their clinical utility, regulatory approval, and widespread adoption. A major question in the
psychedelic field is whether the hallucinations can be separated from the antidepressant effects, or if they
themselves confer therapeutic effects. The lab of Dr. Olson, a co-sponsor of this proposal, has developed a
non-hallucinogenic serotonin receptor agonist, tabernanthalog (TBG), that shows preclinical antidepressant
effects. The mechanisms of action of this small molecule are not completely understood. TBG has affinity for
multiple receptors and pleiotropic actions within the brain. The availability of hallucinogenic and
non-hallucinogenic compounds with shared therapeutic effects enables studies that to address a major
question in the field: what are the commonalities and differences in drug-induced cellular and molecular
responses between these classes of drugs. I will use paired snRNAseq and snATACseq as well as
complementary histology and epignenomics assays to characterize the transcriptomic and epigenomic
changes mediated by TBG and a hallucinogenic psychedelic, 5-Methoxy-Dimethyltryptamine (5-MeO-DMT)
24 hours after administration. I will test for cell type specific effects that are shared or differ between drugs
and test if cellular responses are correlated with expression of the presumed relevant receptor protein, the
serotonin 2a receptor. Specifically, I am focused on the synaptic and plasticity related genes that may drive
the persistent therapeutic effects. There have been no reported studies applying these methods to
non-hallucinogenic psychedelics, and most previous genetic studies focus on one or a limited set of genes.
Finally, using paired snRNA and snATACseq will enable both cell-type specific resolution and linking
transcriptomic and epigenetic changes. I will focus on synaptic/plasticity gene loci and attempt to distinguish
signaling aspects that are common to both drugs (and thus potentially driving therapeutic effects).
Additionally, I will test spatial organization of the responsive cells using RNA-FISH and perform histone
CUT&RUN to test for chromatin state changes associated with accessibility and transcriptional regulation.
This work will expand understanding of the mechanisms of action and the target cell types of these
pleiotropic small molecule psychedelic drugs, and do so with multiomic modalities and systems-biology level
of comprehensive analysis not previously attained. This proposal represents a cross-disciplinary effort
linking pharmacology and genomics that brings powerful approaches to understanding basic cellular and
molecular activities underlying promising psychedelic compounds for the treatment of MDD and other
disorders, and these results will have further value towards development of next generation therapeutics.

Public health relevance
PROJECT NARRATIVE Psychedelic compounds with agonism at the serotonin 2A receptor (5HT2AR) have shown positive clinical trial and preclinical data for treatment of psychiatric disorders including major depressive disorder (MDD) for substance use disorder (SUD); however, the utility of many compounds in this class are limited by the concomitant hallucinogenic effects. We are limited in our mechanistic understanding of the cell types and pathways involved in mediating the therapeutic effects which is critical to creating a next generation therapeutic that holds these therapeutic properties without inducing hallucinations. This proposal will compare the cell type-specific transcriptomic and epigenomic signatures induced by a hallucinogenic and a non-hallucinogenic 5HT2A receptor agonist that have both been shown to alleviate symptoms of depression in preclinical mouse models.